Computational and Data Science Approaches to Enhance Biomolecular NMR

Abstract
NMR is one of the most versatile analytic tools for investigating biomolecules. It can probe structure and
dynamics in solution at atomic resolution, even for disordered molecules, and it can quantify the affinity and
kinetics of biomolecular interactions and the sites of interaction. It is capable of quantifying individual
components of complex mixtures of small molecules, with applications to metabolomics, drug discovery, and
clinical diagnostics. The broad goal of this project is to develop computational methods and tools that enhance
the application of NMR in these biomedical applications, by improving sensitivity, resolution, lowering the
barriers to implementing complex experimental and analytic workflows, and making them more reproducible
and the resulting data easier to survey and share. The approach will leverage and enhance the open,
international repository for biomolecular NMR data, the Biological Magnetic Resonance Data Bank, and the
NMRbox computational platform, comprised of >250 NMR-related software packages and high performance
computational and storage resources. Special emphasis is given to the application of NMR for investigating
dynamics and disorder in biological macromolecules, which are inaccessible to other methods, and to the
quantitative analysis of mixtures of small molecules, for NMR-based screening, metabolomics, and biomarker
discovery.

Public health relevance
PROJECT NARRATIVE Advances in biomolecular NMR spectroscopy for applications to challenging biomedical problems in structural biology, metabolomics, biomarker identification and clinical diagnosis, and drug discovery are intimately tied with advances in computation, both hardware and software. The goal of this project is to advance the utility of NMR for these applications, using computational and data science approaches to improve sensitivity and resolution, lower barriers to complex experimental and computational workflows, increase reproducibility, and make it easier to share and survey data.